VS-EDGE: Visual-Semantic Explanations for Diagnostic Guidance

PROJECT SUMMARY
Technological innovations such as computer-aided diagnosis (CAD) systems can be of value in analyzing the
sixty billion radiological images that are generated annually in America’s healthcare sector. However, there is a
large gap between the number of CAD systems reported in the scientific literature and the number routinely
used in clinical practice. This gap can be partially explained by the fact that most machine learning-based CAD
systems function in a “black box” manner, leading to a lack of trust by clinicians in the use of technology to aid
the diagnostic process in clinical settings. Recognizing an object involves rapid visual processing and
activation of semantic knowledge about the object, but how visual processing activates and interacts with
semantic representations for both physician and CAD systems remains unclear. There is, therefore, a critical
need to determine how visual-semantic processing identifies important, clinically significant visual patterns.
The long-term goal is to accelerate the development of technological innovations for improved decision making
in clinical settings. The overall objective for the proposed R15 is to develop and validate a novel model of
visual-semantic processing. The central hypothesis is that a model based on an integrated semantic and
deep-learning neural network (SDNN) can create explainable and accurate CAD mechanisms and establish a
common understanding of what is visually important to radiologists. The rationale is that successful
development of a validated explainable CAD model will provide new opportunities for its continued
development and future clinical use as an aid to physicians making diagnoses. The following two specific aims
are proposed: 1) Develop a Semantic Deep-learning Neural Network (SDNN) that generates visual patterns
and image exemplars; and 2) Determine which visual patterns and image exemplars are diagnostically most
informative. In the first aim, a deep learning model will be designed and developed that, when augmented with
visual semantic knowledge, gives rise to representational features that closely match the visual semantic
concepts represented in human higher-level vision. For the second aim, a panel of experts will be engaged to
identify a set of visual patterns and image exemplars that can be used as potential CAD explanations when
interpreting lung nodules by computer. The proposed research is innovative because it focuses on
integrating visual perception and semantic knowledge and discovering emergent patterns that more closely
match the visual-semantic features represented in human higher-level visual cortex. This proposed research is
significant because the results are expected to provide strong scientific justification for continued development
of future CAD systems augmented with explanations as a gateway between CAD technology and clinical
practice, as well as continued expansion of use of these technologies. Finally, as an R15, this award will be
used to help strengthen the research environment at DePaul University, as well as expose undergraduate and
graduate students to biomedical research, thereby broadening their range of career choices.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because development of a new computer-aided diagnostic (CAD) technology, built on intuitive, broadly applicable explanations, is likely to lead to improved diagnostic accuracy and, importantly, to clinician trust in CAD systems. Once such CAD technology has been developed, significant advances in the clinical use of CAD systems are highly likely, with a resulting decrease in diagnostic errors. The proposed research is relevant to the part of the NCI’s mission that pertains to advanced scientific knowledge and the application of that knowledge to improve cancer prevention, detection, diagnosis, and survivorship.